Regulation of dynamic actin networks during epithelial morphogenesis

Project Summary
Embryonic development requires the dynamic remodeling of epithelial sheets as the embryo
transforms itself during morphogenesis. Understanding these events has important implications
for understanding common human birth defects and common cancers. Our aim is a
multidisciplinary, integrated analysis of morphogenetic movements in embryos that unites
detailed structural analysis, single-molecule biophysics, genetics, and dynamic in vivo analysis,
using the C. elegans embryo as a model system. Our recent focus has been in two broad areas
of cytoskeletal regulation: the mechanisms by which mechanotransduction occurs through the
cadherin/catenin complex during morphogenesis, and cellular mechanisms of epithelial cell
rearrangement driven by basolateral motility. We will continue these emphases here:
1. Define mechanisms of α-catenin mechanotransduction during morphogenesis: We
will examine the tension-dependent interaction of SRGP-1/srGAP with HMP-1/α-catenin and
how SRGP-1 recruitment positively modulates cadherin complex function.
2. Define mechanisms of self-healing of junctional actin networks under tension during
morphogenesis: We will test a model in which different LIM-domain containing repeat
(LCR) proteins stabilize different substructures with the junctional proximal F-actin network
under tension to prevent self-injury.
3. Define mechanisms of local actin polymerization in during epithelial cell
rearrangement: We will use an integrated approach to determine how CRML-1/CARMIL
negatively regulates motility via effects on the barbed end actin capping machinery.
4. Define local signaling pathways that promote polarized motility during cell
rearrangement: We will determine how additional signaling components regulate epithelial
cell rearrangement.
As a result of these studies, we will gain new insight into how adherens junctions are able to
withstand and respond to tension in a living organism, and we will elucidate a novel pathway
regulating cell intercalation via basolateral protrusive activity. Each project has widespread
implications for understanding processes crucial for diverse cellular events during human
development and disease.

Public health relevance
Project Narrative Understanding how cells attach to one another and move between one another is important for understanding many common birth defects, and many of the same processes that are tightly regulated in embryos are misregulated in cancer cells as they lose their connections to one another and invade the body. This proposal examines how actin – a protein essential for cell movements – works alongside proteins that regulate cell adhesiveness to build strong connections between cells and to help them avoid injury, and how signals regulate the actin machinery that allows cells to change position in the embryo.